A humanized monoclonal FSH antibody for Alzheimer's Disease and co-occurring health conditions in Down Syndrome

Project Summary/Abstract
People with Down Syndrome have many co-occurring health conditions, but one of the most common is
Alzheimer’s Disease. People with Down Syndrome begin to accumulate Alzheimer’s pathology at much earlier
ages than people without Down Syndrome. Accordingly, by the age of 60, almost all people with DS will be
symptomatic for Alzheimer’s Disease dementia, whereas less than 10% of people without Down Syndrome will
have Alzheimer’s Disease dementia. Because Alzheimer’s Disease impacts virtually all people with Down
Syndrome, developing interventions to block or slow the progression of Alzheimer’s Disease may be especially
helpful for increasing the quality of life for people with Down Syndrome.
Our previous work showed that elevated levels of follicle-stimulating hormone (FSH) enhance the genesis and
progression of Alzheimer’s pathology in mouse models of Alzheimer’s Disease. This led us to wonder whether
Down Syndrome might be associated with elevated levels of FSH. Here, we will first measure FSH throughout
the lifespan in two mouse models of Down Syndrome and explore possible mechanisms by which FSH might be
altered in Down Syndrome. In our published work, we also developed a first-in-class monoclonal antibody
targeting FSH; the antibody binds to the FSH receptor thereby preventing FSH from acting on its’ receptor. We
will then determine whether administration of this antibody late in the lifespan reduces age-related accumulation
of Alzheimer’s-like pathology in mouse models of Down Syndrome, as well as cognitive function. Lastly, we will
compare antibody administration in young and aged mice with Down Syndrome and examine the impact on
metabolic and non-metabolic conditions that are highly prevalent in Down Syndrome and arise from FSH-
sensitive organs. The overarching goal of our proposed work is to determine if and when FSH is elevated in
Down Syndrome, and probe whether reducing the actions of FSH helps normalize physiological function, thereby
unmasking a new therapeutic target for the treatment of multiple co-occurring diseases in Down Syndrome.

Public health relevance
PROJECT NARRATIVE Virtually all people with Down Syndrome will develop Alzheimer's Disease dementia. We previously showed that a hormone called follicle-stimulating hormone (FSH) can increase the development of Alzheimer's pathology in the brain. In the proposed work, we determine whether Down Syndrome is associated with changes in FSH in mouse models of Down Syndrome and ask whether decreasing the signaling of FSH in mouse models of Down Syndrome reduces Alzheimer's-like pathology and helps restore function in other organ systems.